Proteomic identification of Myalgic encephalomyelitis/chronic fatigue syndrome

Myalgic Encephalomyelitis/Chronic Fatigue Syndrome (ME/CFS) is a major disabling illness of unknown etiology.
It directly impacts more than one million Americans. The lack of validated biomarkers to distinguish this
condition from other illnesses characterized by fatigue leads to diagnostic unsurety with negative
consequences for the patient: often, health practitioners do not believe the illness is real – thus leading them
to tell patients there is nothing wrong with them – producing anxiety in the patient and a feeling of being
stigmatized. Recent research points to the brain as the probable organ responsible for ME/CFS. If we could
identify one or more biomarkers in the most relevant site, the cerebrospinal fluid bathing the brain, those findings
would simplify diagnosis and accelerate research -- outcomes that could lead to novel treatment strategies.
Until the past few years, technology was not sufficiently developed to achieve this goal. That is no longer the
case. The Specific Aim of this proposal is to identify the protein biomarker or biomarkers that are
diagnostic of ME/CFS-at-large. To achieve this Aim, we will take advantage of new technological advances,
many developed by members of our team. Our preliminary published data have shown that there is a biological
basis for ME/CFS and that biomarkers do exist. But we do not know which are most common across most
patients. Thus, while the results of our earlier study were a positive indicator, the technology available was not
sophisticated enough to provide quantitative data to define those proteins that will differentiate ME/CFS from
healthy controls or from patients with other neurological diseases associated with fatigue. To do this, we will use
cerebrospinal fluid samples collected from 35 patients with ME/CFS, taking no brain-active medications, to
identify which of the many candidate proteins singularly or in combination are present in the greatest number of
ME/CFS patients. We will use an advanced combination of protein fractionation and mass spectrometry
methods, all of which are currently in operation, to achieve this goal. We are in a unique position to accomplish
our Specific Aim because we have: the required samples already banked, a team of physician-scientists,
leading pioneers in mass spectrometry and proteomics, experts in statistics and bioinformatics, technical
personnel in place, and experience with all the methods.

Public health relevance
Narrative Myalgic encephalomyelitis/Chronic fatigue syndrome (ME/CFS) is an illness diagnosed by clinical criteria. We plan to use banked spinal fluid to arrive at a list of possible protein biomarkers that separate ME/CFS from healthy controls and patients with other neurological reasons for severe fatigue.